DEVELOPMENT OF SAFE TECHNIQUES FOR SELECTIVE ACTIVATION

The specific object of this contract is to develop neural stimulating electrodes and to evaluate the effects of electrical stimulation on neural and surrounding tissue in non-human animals.